DEVELOPMENT OF NEW ANTISEIZURE DRUGS FROM PHENOLS

DESCRIPTION: (Applicant's Abstract) The objective of this project is to synthesize new anti-seizure medications based on certain naturally occurring phenols. Pharmacognetics isolated a naturally occurring phenol derivative from a plant which had historically been used to treat seizures. This compound and several related naturally occurring compounds have shown significant anti-seizure activity. There is evidence that modification of these naturally occurring compounds yields more potent anti-seizure compounds that are virtually devoid of side effects in rodent testing. Pharmacognetics plans to (1) synthesize analogs of substituted phenols with known anti-seizure activity as well as several closely related compounds; (2) test these compounds for anti-seizure activity, adverse effects and toxicity; and (3) further explore structure-activity relationships and mechanisms of these compounds. The goal of this Phase I proposal is to synthesize one or more lead compounds which maximize anti-seizure potency while minimizing adverse effects.